The Interactive Effects of Caffeine and Cannabis Use on Neurocognitive Outcomes in Adolescents and Young Adults

PROJECT SUMMARY/ABSTRACT. Nearly 87% of adolescents consume caffeine in some form, and both
rates and quantities of caffeine consumption increase as adolescents transition into young adulthood. Although
investigations into adult caffeine use are well studied, there is a paucity of research on the effects of early
adolescent caffeine initiation and chronic use. Of further concern, these increases in caffeine consumption
coincide with increases in other substance use including cannabis use, with 37% of high school seniors
reporting past year cannabis use. Preclinical models have shown that even after caffeine cessation, adolescent
caffeine exposure can lead to increased susceptibility of future substance use. Additionally, some preclinical
models have demonstrated that concurrent caffeine and cannabis use exposure may lead to decreases in
cognitive performance mediated through hippocampal dysfunction. Despite this early evidence, there have
been limited longitudinal investigations into adolescent caffeine consumption and concurrent cannabis use and
no studies examining their interactive effect on cognition in human adolescents. The primary aim of the current
K08 proposal is to address this gap in the literature by examining longitudinal trends in caffeine consumption;
measure the impact of caffeine exposure on future cannabis use; and investigate how the combined effect of
caffeine and alcohol use impacts neurocognitive trajectories through random intercept cross-lagged panel
models. By leveraging data from the Adolescent Brain Cognitive Development (ABCD) study, long-term consist
trends in caffeine consumption and substance use can be assessed throughout adolescence. Additionally,
harmonized studies such as the Protracted Understanding of Fluctuating Substance use and Severity Study
(PUFFS) can be employed to gain an understanding of how these trajectories may change as adolescents
transition into young adulthood. As both studies incorporate detailed clinical interviews of substance use,
including caffeine use, aggregates of total self-reported caffeine use across multiple caffeine modalities are
collected, which provides a novel opportunity to calculate estimates of overall caffeine consumption. The
proposed project offers Dr. Wallace an opportunity to gain additional training in adolescent caffeine research,
which is largely missing from the adolescent addiction field, as well as mentorship in complex longitudinal
statistical modeling across multiple datasets. A mentorship team of experts will bridge these unique fields to
improve our understanding of the effects of caffeine exposure and concurrent cannabis use on adolescent
cognitive development. These experiences would build off of Dr. Wallace’s previous experiences with cross-
sectional cannabis use research on the developing brain. At the conclusion of this award, Dr. Wallace will meet
his goal of career independence as a clinical research scientist with expertise in adolescent caffeine
consumption in the context of addiction and longitudinal analyses, which will be exemplified by submission of
an R01.

Public health relevance
PROJECT NARRATIVE Rates of caffeine use start to drastically increase during adolescence through young adulthood; however, the long-term effects of chronic adolescent caffeine consumption are understudied. This utilization of caffeine happens at a time when cannabis use is also increasing, which is of concern given the potential potentiating effects of caffeine on concurrent cannabis use and the developing brain. Here we propose utilizing secondary longitudinal data to examine how caffeine use in adolescence and young adulthood impacts cannabis use trajectories as well as the interactive effect of concurrent caffeine and cannabis use on cognitive functioning over time.